PNA-STAMPs: Versatile, Potent and Targeted Antibiotics

Project Summary
There is a critical need to develop therapies targeting Streptococcus pneumoniae (Spn): a major human
pathogen contributing to global morbidity and mortality. We propose to use Specifically Targeted Anti-Microbial
Peptides (STAMPs), where a broad spectrum anti-microbial peptide (AMP) is fused to a Spn secreted peptide.
The former will provide anti-microbial activity, while the latter will impart selectivity of this activity at the taxonomic
level or increase efficacy of the AMP. This project builds on preliminary data where we show that human beta-
defensin 3 is ineffective in killing Spn. In contrast, a fusion of this AMP to a Spn cell-cell communication peptide
resulted in a peptide that eliminated >95% of Spn in culture. Further, we propose an innovative way to produce
STAMP peptides, where we will deploy a “molecular velcro” technology based on complementary peptide nucleic
acid (PNA) adapters. These PNA adapters are connected to the ends of independent targeting and AMP domains,
allowing facile assembly and screening of PNA-STAMP libraries. Conclusion of the proposed work will introduce
species-specific antimicrobials for Spn targeting and develop a conceptual and technical platform for the
development of Gram-positive antimicrobials.

Public health relevance
Project Narrative We aim to develop Specifically Targeted Anti-Microbial Peptides (STAMPs), where one or more Spn peptides direct the activity of an anti-microbial peptide (AMP) to kill Streptococcus pneumoniae (Spn), a major cause of morbidity and mortality worldwide. Our target peptide will be derived from Spn cell-cell communication peptides and will be linked to an AMP via complementary peptide nucleic acid (PNA) adapters. Conclusion of the work will lead to the production of a set of PNA-STAMPs that may efficiently and specifically kill Spn in planktonic cultures and biofilm; it will also provide a framework for the production of PNA-STAMP libraries to expand therapeutics targeting Spn and Gram-positive bacteria.